PERFORMANCE AREA 1 - MANAGEMENT AND OPERATIONS SUPPORT

Pharmacology and Toxicology for Therapeutics Program; Small Molecules; Blueprint Neurotherapeutics

Public health relevance
Support development of promising therapies for neurological disorders